Implementation of automated staining in conjunction with spatial analyses

Project Summary
We are in the process of building a facility that will take advantage of emerging spatial transcriptomic and
proteomic technologies to study the immune landscape in clinical samples. Originally developed under the aegis
of the Mayo Clinic Breast Cancer Translational Genomics initiative, the Spatial Biology facility focuses largely on
analysis of solid tumors. Our central objective is to define the fundamental properties that underlie the
relationship between clinical phenotype (most commonly therapeutic response) and the number, types, activities,
and locations of immune cells within the tumor. It has, however, become increasingly clear that similar features
may underlie neurodegenerative diseases of aging; and we have initiated several projects related to the immune
landscape of Alzheimer’s disease and neuronal aging in mouse models.
Our core technology is NanoString GeoMx, which enables us to interrogate the transcript and/or protein
expression profiles of user-defined areas of interest in a single 5-micron formalin-fixed, paraffin-embedded tissue
section. We routinely carry out a range of analyses, from digital spatial profiling of multi-plex protein abundance
to whole transcriptome analysis. These applications utilize the GeoMx platform, which we have been running
since September 2019. We are currently beta testing the NanoString CosMx platform, which provides single cell
level resolution for both transcriptomic and proteomic analysis.
The Spatial Biology facility is fully operational at this time. The model is something of a hybrid between a
collaborative arrangement and a core facility. We play a very active role in experimental design of these spatial
biology projects, and we recover costs through a recharge mechanism. The demand for these services has been
little short of overwhelming. To date we have analyzed almost 4000 clinical samples. All of these sample were
processed manually, including a rather labor-intensive staining procedure that requires the better part of two
days. Our goal is to automate this step, thereby providing for increased throughput, experimental consistency,
and more efficient use of time for our limited personnel. To this end, we are requesting funds to purchase a Leica
Bond RXm autostainer.

Public health relevance
Project Narrative Our objective is to increase sample throughput, ensure consistency in sample preparation, and make more efficient use of the limited personnel assigned to the Mayo Clinic Spatial Biology facility. We propose to automate the staining process that initiates proteomic, transcriptomic, and single cell applications of NanoString GeoMx and CosMx technology. To this end, we are requesting funds to purchase a Leica Bond RXm autostainer.